Summer Research Experience in Neurobiology at The Jackson Laboratory

PROJECT SUMMARY/ABSTRACT
The Jackson Laboratory (JAX) proposes to renew the existing summer research experience in neurobiology and
continue to support a focused neurobiology cohort within the existing JAX Summer Student Program, an
internationally recognized research education program for undergraduates and high school students. Under the
proposed renewal, six undergraduate students will conduct neurobiology research in the labs of 11 NIHfunded
neuroscientists who lead cutting-edge, collaborative research programs in Alzheimer’s disease, peripheral
neuropathies, motor neuron degeneration, synaptic development, retinal disease and glaucoma, addiction, Rett
syndrome, and sensory disorders. The 10-week residential internship will provide each participant a summer
salary and funds to support student research supplies and travel to national meetings to present findings. The
proposed program will offer an intense research internship in neurobiology with a focus on the laboratory mouse
as an investigative tool to probe the basic mechanisms of human biology and disease. As a member of the
mentor’s laboratory team, each student will design and conduct an independent, hypothesis-driven project using
advanced analysis methods and tools and the outstanding genetic resources available at JAX. The defined
research education curriculum will include asynchronous online learning modules, bioinformatics bootcamps,
workshops on the ethical conduct of research within historical and modern scientific contexts, and science
communication. JAX institutional commitment includes student access to intellectual and research resources
such as on-campus courses and conferences, state-of-the-art instrumentation and bioinformatics databases,
dedicated program direction by JAX Genomic Education, and a staffed on-campus residential program. The
neurobiology cohort will join the Summer Student Program, which is supported by institutional funds, private
foundations, and federal grants, and has well-established administrative procedures for recruitment and
selection, mentor training and support, and program design, management, and evaluation. The program will
identify participants through a national recruitment and competitive application process. JAX will recruit students
underrepresented in biomedicine through targeted outreach and partnerships. JAX offers a stimulating
environment in which motivated, talented students from diverse backgrounds can learn the fundamentals of
scientific inquiry, contribute to real research progress, and make great strides in intellectual and personal growth
that will guide them toward a career in research.

Public health relevance
PROJECT NARRATIVE A trained and diverse biomedical workforce requires support of educational programs at all levels, including those designed to provide students exposure to biomedical research, reinforce their intent to graduate with a science degree, and to prepare them for graduate studies leading to a career in research. The proposed summer research program will provide opportunities for students to improve their research skills and gain confidence in the research environment.